ALTERATION OF NORMAL GASTRIC FLORA IN NEONATES RECEIVING RANITIDINE

Our hypothesis is that administration of ranitidine to NICU patients will lead to an increase in gastric pH to greater than or equal to 4 which will lead to colonization of the infant's stomach with bacteria and fungi.